Instituting NCI-funded thyroid and head and neck cancer studies

PROJECT SUMMARY/ABSTRACT
Advancements in rare cancers can rarely be done outside of the National Cancer Institute (NCI) clinical trials
network. Clinical studies for rare cancers need many institutions to participate and, due to their low incidence,
are unlikely to be as profitable to the pharmaceutical industry as compared to advancements in treatment for
more common cancers. Anaplastic thyroid cancers and oncocytic (formerly known as Hürthle cell) thyroid
cancers are two prime examples of rare tumors with minimal prior research being done. Eric Sherman, MD, led
and completed the first randomized studies conducted through the NCI clinical trials network that were focused
on these cancers (RTOG-0912, A091302) as well as accrued the highest number of patients to both studies.
Further support will help in these endeavors as Dr. Sherman focuses on developing future studies in rare cancers
of the head and neck as well as supporting the success of both these and other studies of rare head and neck
cancers both in the cooperative group setting (through both the Alliance in Clinical Trials for Oncology and NRG
Oncology groups) and the Cancer Therapy Evaluation Program (CTEP; as part of the CTEP Anaplastic Thyroid
Cancer Task Force and the NCI Head and Neck Rare Tumor Task Force). As part of his role at Memorial Sloan
Kettering Cancer Center (MSK) as the Scientific Director of the Head and Neck Oncology Service and Co-Chair
of the MSK Research Council, he will play a significant role in bringing NCI-supported studies to the institution
and helping with their success.

Public health relevance
PROJECT NARRATIVE Advancements in the management of rare tumors depend on the success of establishing and enrolling patients onto clinical trials sponsored through the National Cancer Institute (NCI) network groups. In addition, the importance of supporting the establishment of scientifically-driven and methodologically-sound clinical trials through the cooperative group system, NCI steering committees, and each institution’s review process is essential for the ultimate success in completing these studies and improving treatment options for patients with rare tumors. The NCI R50 Research Specialist (Clinician Scientist) Award will help provide Eric Sherman, MD, with the necessary protected time to continue to expand his leadership roles to conceptualize studies focused on rare tumors, maximize patient enrollment, and support data analysis of NCI-sponsored clinical trials conducted at Memorial Sloan Kettering Cancer Center.